REGULATION OF APOB METABOLISM IN HUMANS

Our studies will focus on the regulation of plasma triglyceride and cholesterol levels in normals and hyperlipidemics. Rates of production and catabolism of VLDL, IDL and LDL will be quantitated using radiolabeled lipoproteins as tracers. The results should allow us to define the defects in lipid transport present in patients predisposed to atherosclerosis.